Administrative Core

ABSTRACT – Administrative Core
The Administrative Core of the Duke Cancer Health Disparities (DCHD) P20 SPORE is responsible for
organizing and supporting two full translational research Projects; two Shared Resource Cores; a
Developmental Research Program (DRP); and a Pre-CEP (Career Enhancement Program, supported by
institutional resources), as the forerunner of our future P50 CEP. The Core is responsible for transition planning
for this DCHD P20 to compete for a full P50 SPORE grant. The Core will provide leadership, coordination,
oversight, infrastructure, and support personnel to facilitate administrative management; promote integration,
communication, and collaboration; ensure fiscal and regulatory compliance; and oversee data operations,
scientific rigor, and research progress. By serving these functions, the Core will allow investigators to focus on
conducting and disseminating translational science supported by this Program. Steven Patierno, PhD, contact
PI of this P20 SPORE, will lead this Core. Dr. Patierno will receive expert advice, assistance, and guidance
from three oversight bodies: an Executive Committee (EC) of all Project Leaders, and Core and Program
Directors, as well as Internal (IAB) and External Advisory Boards (EAB), both of which include patient
advocates. The team also benefits from an experienced Administrator, and professionals with extensive fiscal
and regulatory compliance experience. The P20 SPORE’s strong leadership and infrastructure, bolstered by
Duke’s commitment to and investment in cancer disparities research, will accelerate advancement toward our
goal of developing precision medicine interventions to mitigate cancer health disparities. The Specific Aims of
the Administrative Core are to provide administrative management and oversight (Aim 1); provide financial
management and ensure compliance with fiscal and research policies (Aim 2); provide oversight of all data
operations (Aim 3); promote integration within the P20 SPORE and the Institution (Aim 4); provide scientific
management to evaluate Program and research progress (Aim 5); and plan transition of the DCHD P20 to a
full P50 Cancer Disparities SPORE (Aim 6). The Core will monitor research progress and productivity, scientific
rigor and transparency, and effective use of Shared Resource Cores. With the EC, the Core will lead strategic
planning and implementation of activities to prepare this Program’s competitive P50 application; develop and
implement strategies to address progress, plans, challenges, and solutions, including initiation of formal
processes to replace Projects when needed; and evaluate DRP Project proposals. This Core also will connect
with quality assurance oversight provided by Duke Office of Regulatory Affairs and Quality. Finally, through
formal evaluation processes involving an external evaluation contractor, the IAB and EAB, the Core will facilitate
assessment of all activities and implement recommendations, guidance, and direction to enhance success.

Public health relevance
PROJECT NARRATIVE – Administrative Core Cancer health disparities are part of a complex, multi-level problem driven by social, psycho-social, lifestyle, environmental, health system, and biological determinants of health. This Administrative Core provides infrastructure, leadership, coordination, integration, and oversight for the Duke Cancer Health Disparities P20 SPORE to enable its translational research designed to develop or improve new or existing interventions and therapies through a better understanding of cancer disparities prevalent in the Duke Cancer Institute’s catchment area.